PHARMACOKINETIC AND ORAL BIOAVAILABILITY STUDIES IN RATS

The purpose of this task order is to identify suitable formulations for administration of potential drug candidates to rats for early pharmacokinetic studies and to characterize the plasma pharmacokinetics (PK) and bioavailability of anticancer compounds in rats. Chemical structures, molecular weight (MW), and other available properties of test agents will be provided and should be used to provide guidance on formulation approaches (e.g., pH-adjustment, co-solvents). Route and dose level (mg/kg) targets will be provided.
There will be a base period and optional tasks included under this task order. The base period will provide for formulation optimization/solubility assessment and one (1) rat pharmacokinetic study with one (1) compound.